Dissecting Molecular Mechanisms of Tumor-Induced Myeloid-Mediated Immune Suppression in Triple-Negative Breast Cancer

PROJECT SUMMARY
Breast cancer remains the leading cause of cancer-related mortality in women worldwide. Despite considerable
progress in the treatment of early-stage disease, a significant frequency of patients will develop recurrence with
distant metastases. Triple-negative breast cancer (TNBC) is the most aggressive subtype with a dismal
prognosis; it lacks the estrogen receptor, progesterone receptor, and HER2 expression and, therefore, is
resistant to treatments targeting those pathways. Interestingly, harnessing the immune system through
immunotherapy with immune checkpoint inhibitors (ICIs) has improved survival rates; albeit modestly, when used
in combination with standard-of-care chemotherapy. Thus, TNBC remains a neoplastic disease with unmet
clinical challenges. New preliminary data in our laboratories indicate that loss-of-function of TAZ, the key
component in the Hippo signaling pathway, inhibits tumor progression in mouse models of TNBC in immune
competent, but not immune deficient mice, indicating that tumor TAZ expression plays an underappreciated
extrinsic role in TNBC biology. Mass cytometry analysis suggested that tumor TAZ expression acts extrinsically
to regulate the recruitment and/or function of myeloid-derived suppressor cells (MDSCs) and, perhaps, tumor-
associated macrophages (TAMs), and regulatory T cells (Tregs). Additional mechanistic studies showed that
TAZ knockdown in preclinical TNBC models led to a reduction in MDSCs, as well as a reduction in the expression
of several cytokines/chemokines, particularly CCL20, potentially linked to the mobilization of MDSCs. Thus,
these findings implicated a previously unrecognized biology of tumor-intrinsic TAZ expression in regulating TNBC
progression via its actions on the immune-tumor microenvironment (TME), notably MDSC trafficking. The overall
objectives of this proposal are to understand the underlying molecular mechanisms by which TAZ expression
regulates the accumulation of immune suppressive cells like MDSCs in the TME of TNBC. Our central
hypothesis is that TAZ expression in TNBC regulates the TME landscape via cancer cell non-autonomous-driven
mechanisms. Our long-term goals are to decipher the crosstalk between TAZ expression in TNBC and the
immune contexture of the TME to uncover new prognostic or therapeutic targets in TNBC biology. To achieve
these goals, we propose the following three aims: 1) determine the impact of tumor-intrinsic TAZ expression on
the immune-tumor microenvironment in preclinical models of TNBC; 2) determine the molecular mechanisms by
which tumor-intrinsic TAZ expression recruits MDSCs to the TME; and 3) determine the relationship between
tumor TAZ expression and the immune-tumor microenvironment in patients with TNBC. A major impact of this
study is to identify previously undescribed TAZ-mediated mechanisms that will unveil new biomarkers or inform
novel therapeutic interventions for advanced or metastatic TNBC.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Triple-negative breast cancer (TNBC) is considered the most aggressive subtype of breast cancer, and patients with TNBC exhibit a poor prognosis, despite current treatment regimens. Although the reasons for such poor survival outcomes remain incompletely understood, it has become clear that non-cancerous cell types within the tumor microenvironment (TME) are integral players in disease progression and resistance to diverse oncologic therapies. Here, we seek to decipher a novel biology of a previously identified oncogene known as TAZ in TNBC progression, a biology that governs the mobilization of pro-tumorigenic myeloid populations to the TME and one that also provides opportunities for novel biomarker or therapeutic target discovery.